Structural and Functional MRI of the Cervical Spinal Cord in Multiple Sclerosis

Project Summary
This proposal aims to extend our work investigating functional connectivity in the human cervical spinal cord
(CSC) using resting state functional MRI (rsfMRI) to relate CSC function to 1) structural abnormalities and 2)
clinical, neurological function in patients with multiple sclerosis (MS). We propose that functional connectivity
as measured by spatially correlated blood oxygenation level dependent (BOLD) signals may provide an
unprecedented biomarker for CSC function, recovery, and treatment in MS patients, for which there is currently
no non-invasive imaging method. rsfMRI in the brain has been widely studied, yet similar studies in the CSC
are lacking. Our group first reported detection and quantification of spatially correlated, low-frequency BOLD
signal fluctuations in the CSC in a resting state in healthy volunteers and we show, herein, in patients with MS.
Our scientific premise is that much of the neurological deterioration experienced by MS patients may arise from
SC damage and in the resting state, alterations in neural synchrony responsible for maintenance of SC
function will provide a novel, objective biomarker for studying the functional health of the CSC in MS patients.
Our lab has also pioneered advanced, quantitative MRI (qMRI) for the CSC in MS, and we will, for the first
time, relate changes in qMRI indices reflective of axonal and myelin health, as well as lesion burden, and
tissue atrophy to alterations in resting-state CSC function. We propose to utilize technical developments for
transitioning recent work to 3T, and also clinical validation of these approaches assessing the added value of
CSC rsfMRI. We aim to 1) further develop robust, reliable methods to detect and quantify functional
connectivity in the human CSC by optimizing acquisition and analysis for 3T deployment, 2) to relate rsfMRI
abnormalities to structural, and qMRI (Diffusion Tensor Imaging and Quantitative Magnetization Transfer), and
3) to relate rsfMRI aberrations to neurological impairment, and evolution. rsfMRI will be related to spatial
distribution of lesions, lesion burden, and qMRI-derived indices within and across CSC segments. Lastly,
measurements of rsfMRI connectivity will be correlated with a battery of targeted neurological assessments
that probe an MS patient’s neurological performance to establish the relevance of rsfMRI changes to MS
impairment. We hypothesize that increased structural abnormalities will result in greater rsfMRI connectivity
alterations, though neurological presentation may not be as easily related. Therefore, the significance of this
proposal is that we will, for the first time, comprehensively assess CSC function and structure to understand
the neurological-radiological discordance in patients with MS. If successful, we will establish that rsfMRI
studies of the brain can be deployed to objectively evaluate functional circuitry and synchrony within the CSC
and show that measures derived from CSC rsfMRI assessment are relevant for assessing clinically manifest
function, or loss of function. The opportunity to assess functional connectivity in the resting state has further
benefit in patients who have limited neurological function or present with spinal cord predominant disease.

Public health relevance
Project Narrative Multiple sclerosis (MS) is one of the most prevalent and debilitating neurological diseases that affects patients in early adulthood and in fact, is the second leading cause of non-traumatic paralysis. Importantly, the spinal cord is often thought to be the site of involvement that drives neurological deficits experienced by patients, however, there are no non-invasive imaging methods to probe spinal cord function, and structural magnetic resonance imaging (MRI) does a poor job at relating SC injury to neurological deficiencies in MS. Recently we have developed improved quantitative MRI and resting-state functional MRI to derive GM connectivity within the cervical spinal cord at 7T, but realize there is a need to translate that to more readily available field strengths, test the structure function relationship between lesion presence and spinal cord dysfunction, and relate MRI changes seen in the spinal cord to a patient’s clinical disability.